New Mexico IDeA Networks of Biomedical Research Excellence (INBRE)

PROJECT SUMMARY
This project is a continuation of the New Mexico Idea Network of Biomedical Research Excellence (NM-
INBRE), a statewide network that builds biomedical and community-based research capacity. The population
of the State of New Mexico is majority-minority, lives mostly in rural areas, and is economically disadvantaged.
The NM-INBRE program supports faculty research and professional development, encourages primarily
undergraduate institutions to build their research culture, and provides formal research experiences to
undergraduate students. Further, the NM-INBRE provides valuable access to data science technologies by
providing consultation services, intensive training, and direct support for cloud computing resources to the
faculty and students at NM-INBRE partner institutions. The network includes ten institutions of higher education
and two Tribal Communities. NM-INBRE’s effective organizational structure includes institutional cooperation
and recognition of each partner's important and unique roles. The proposed NM-INBRE_5builds upon prior
scientific achievements, to facilitate effective integration of training and research using data science
technologies, connect new investigators with established mentors and collaborators, and contribute to
developing New Mexico's biomedical research workforce. The specific aims are: 1. To enhance the established
multi-disciplinary research network that strengthens the lead and partner institutions' biomedical research
expertise, infrastructure, and research environments, especially at primarily undergraduate institutions (PUI),
2. To provide support to faculty research programs at participating institutions through developmental research
funding, access to critical research-enabling technologies and processes, mentorship, and various professional
development activities, 3. To provide research opportunities and training for students from primarily
undergraduate institutions, community colleges, and minority-serving institutions to build a pipeline to health-
research careers within IDeA states, 4. Encourage collaborative, interdisciplinary research among NM-INBRE
investigators (within New Mexico and in other INBRE states), and between NM-INBRE and COBRE
investigators. Organizations participating in NM-INBRE include the non-PUI institutions New Mexico State
University (NMSU) as the lead institution, the University of New Mexico, both main campus and its Health
Sciences Center (UNM), the National Center for Genome Resources (NCGR), and Burrell College of Medicine
(BCOM). Partner PUI institutions include Dona Ana Community College (DACC), Eastern New Mexico
University (ENMU), New Mexico Institute of Mining and Technology (NMT), New Mexico Highlands University
(NMHU), Northern New Mexico College (NNMC), San Juan College (SJC), and Western New Mexico
University (WNMU).

Public health relevance
Project Narrative: The NM-INBRE program provides research, training, and career development opportunities for early-career faculty and students at all levels of education. We deliver innovative biomedical research that contributes to improving human health, especially to underserved populations in New Mexico.